Time Sensitive Award Mechanism - Using Exposure Science to Identify Populations at Risk in the Aftermath of Hurricane Harvey: administrative supplement

Document not required

Public health relevance
Document not required